A Bio-Inspired Artificial Transcription Factor for Regeneration of Functional Hair Cells

PROJECT SUMMARY
Hearing loss during early childhood significantly affects learning and acquisition of social skills, while hearing
loss in adults can often result in social isolation and inability to perform many routine social functions. A leading
cause of sensorineural hearing loss is the loss of sensory hair cells of the inner ear. A lifetime exposure to
aminoglycoside and loud sounds will result in an estimated 15% of adult Americans (~36 million) having some
form of hearing loss. A promising approach to mitigate hearing loss and deafness is a cell replacement therapy
by transdifferentiating supporting cells into hair cells. Unfortunately, current approaches for transdifferentiation
rely on viral delivery may be unsafe and impractical for clinical translation. Therefore, there is a critical need to
develop alternative platforms to regulate gene expression and induce transdifferentiation in an efficient, non-viral
manner suitable for hearing restoration.
To this end, our long-term goal is to develop NanoScript, an innovative, tunable nanoparticle-based artificial
transcription factor platform capable of effectively regulating gene expression in a non-viral manner. Using
NanoScript, we will transdifferentiate supporting cells into functional hair cells. NanoScript consists of a
nanoparticle functionalized with specific small molecules and peptides that are designed to mimic the individual
domains of natural transcription factor (TF) proteins. TFs are endogenous, multi-domain proteins that orchestrate
many cellular functions including differentiation. Since NanoScript is a functional replica of TF proteins, it can
replace virally-delivered TFs for regenerative medicine-based applications. The overall objective of this proposal
is to design three NanoScripts that mimic three TFs essential for hair cell differentiation (Gfi1, Pou4f3, and Atoh1;
GPA). We will test whether GPA-NanoScript binds to the same DNA sequence and activate gene expression in
vitro. Next we will determine if addition of epigenetic modulators to GPA-NanoScript will bind to the same targets
as the TF proteins, locally alter the chromatin structure and enhance gene expression. Finally, we will use
cochlear explants to determine whether GPA-NanoScript promotes transdifferentiation of supporting cells into
hair cells. Generation of nascent hair cells using an ex vivo model will serve as a springboard to test NanoScript
technology for regenerative medicine. It will also establish NanoScript as an effective and non-viral tool for
researchers to generate functional cells via direct reprogramming.

Public health relevance
PROJECT NARRATIVE Sensorineural hearing loss is major public health concern that results from hair cell loss in the cochlea. Development of nanoparticle-based synthetic transcription factors that promote transdifferentiation of cochlear supporting cells into functional hair cells can be used to alleviate hearing loss. Use of NanoScript will be the first step towards a hearing loss therapy and is relevant to the component of NIH’s mission to investigate how innovative technology can be safely translated for clinical use in treating human illness and disability.